Summer Biomechanics, Bioengineering, and Biotransport Conference

PROJECT SUMMARY
This proposal seeks NIH support for the 2023-2025 Summer Biomechanics, Bioengineering, and Biotransport
Conferences (SB3C). SB3C fills an important niche by providing a broad based, mid-sized meeting focused on
bioengineering. The SB3C program includes plenary, oral, and poster sessions covering scientific content in
Cell and Tissue Mechanics, Fluid Mechanics, Biotransport, Design and Rehabilitation, Solid Mechanics, and
Education. SB3C offers interactive workshops on topics including diversity mentorship, professional
development, novel educational approaches, and advanced research techniques.
The mission of SB3C is to promote state-of-the-art research, collaboration, scientific discourse, and enhance
diversity in bioengineering. SB3C is a student-focused conference, with students typically comprising over 50%
of attendees. Students at all levels can participate in the Student Paper Competition; network with established
investigators at the Diversity Mentor-Mentee Workshop or the Women’s Networking Event; and enjoy social
interactions with peers through activities organized by the Student Leadership Committee. SB3C awards
Diversity Travel Grants to enable students from underrepresented groups in biomechanics to attend the
conference and keeps student registration fees low by seeking support from NIH, NSF, and industry and
academic sponsors.
The 2023 SB3C Organizing Committee is a diverse group of experienced SB3C organizers and emerging
leaders in bioengineering. We will continue successful scientific and diversity programs and innovate in several
ways. The specific aim of this proposal is to support student participation in SB3C 2023-2025, with the goal of
increasing the number of student attendees who come from groups traditionally underrepresented in
bioengineering. We seek financial support from NIH to maintain low registration fees for students who cannot
otherwise attend the in-person conference. We are confident that we can create a high-quality in-person
conference with high-quality virtual content.

Public health relevance
NARRATIVE The 2023-2025 Summer Biomechanics, Bioengineering, and Biotransport Conferences provide opportunities to share current bioengineering research. We ask for NIH support to support our goal increasing the participation of trainees from groups traditionally underrepresented in bioengineering.